Bioprinting Tissue Engineered Vascular Conduits for Treating Single Ventricle Defects

Project Summary
Tissue engineered vascular conduits (TEVCs) offer high potential for treating cardiovascular diseases,
such as single ventricle defects, by repairing damaged tissues and improving circulation. Conduits made of
realistic tissue components present as long-lasting solutions capable of adapting with the body and integrating
with host cells, thus offering enhanced, physiologically mimicking functionality. Bioprinting is an enabling
approach toward generating user-designable tissues, with potential for maximizing accommodation for patient-
specific needs. However, current bioprinting techniques are restricted in the types of materials that can be used
as bioinks, typically relying on artificial materials/modifiers in bioink solutions or extremely high concentrations
and acidity to enable printability, which limit biocompatibility and versatility. Many natural, physiological materials
remain unprintable, especially with direct inclusion of cells within the bioinks. Moreover, key limitations in existing
TEVCs (which are typically not bioprinted) include high incidence of stenosis in patients, thus elevating the risks
of utilizing such products as the clinical gold standard.
In this proposed study, we will develop highly tunable and customizable TEVCs utilizing a novel
bioprinting method capable of directly printing fully physiological materials, including cell-laden tissues. Our
method is fast, enabling rapid production of TEVCs with custom features. We will further incorporate universal
immunocompatible human induced pluripotent stem cell (iPSC)-derived cells, including endothelial cells, in our
bioprinted TEVCs to generate highly biomimicking living vessels with a functional endothelium, which will be
conditioned and matured to enhance vessel function prior to implantation experiments. Matured TEVCs will
subsequently be implanted in vivo into humanized rats to evaluate performance enhancements. Our study will
produce a new generation of TEVCs with significantly enriched functions – custom bioprinted,
immunocompatible living vessels for personalized and off-the-shelf capable regenerative therapeutic
applications. We aim to develop fundamental advances in tissue engineered vessels for treating single ventricle
defects.

Public health relevance
Project Narrative Treatment of diseases caused by defective cardiovascular tissues, such as single ventricle defects, often involves surgical implantation of conduits to alter and improve circulation. Bioprinting functional vascular conduits offers novel enabling tools for cardiovascular repair. Here we apply our novel bioprinting capabilities to generate highly customizable, living, and non-immune-triggering vascular conduits made of physiological materials to provide next-generation, lasting, and native vessel-like regenerative treatment options for patients.